Upregulating spinal circuits to enhance balance and walking and to increase spinal excitability in older adults

PROJECT SUMMARY/ABSTRACT
A high proportion of older adults are currently or soon will be at risk for the well-known decline in walking and
balance abilities that occur with aging. Preserving those abilities has become a major public health priority.
Balance training can enhance functional abilities or attenuate functional decline; however, age-related motor
deficits may impair practice-based motor learning and behavioral performance. Due to the crucial roles of the
spinal cord in balance and walking performance, it is important to consider that age-related neural impairment of
the spinal cord is a likely contributing factor. Specifically, the spinal cord in older adults has fewer neurons, is
less excitable, and conducts signals more slowly. Despite ample evidence of impaired spinal cord neuronal
structure and function with aging, the potential benefit of an intervention targeting spinal control of balance and
walking control has been largely unexplored. This dearth of research may be due in part to the lack of a clinically
feasible intervention. However, the recent emergence of transcutaneous spinal direct current stimulation (tsDCS)
as a non-invasive intervention creates new opportunities for understanding spinal cord contributions to balance
and walking performance. The proposed study will be among the first multi-session trial to investigate the effects
of tsDCS as an adjunct therapy to dynamic balance training in older adults. We propose to include 30 participants
65 years of age or older with balance/walking deficits, who will receive active or sham tsDCS while performing a
dynamic balance training intervention. Balance and walking performance assessments will be conducted after
each of the five intervention sessions to examine the intervention's effects over time. Spinal excitability will be
assessed immediately before and after tsDCS at the first and last intervention sessions. Behavioral assessments
will only be carried out at baseline and 1 day post-intervention to investigate the pre vs. post intervention effect,
with a 10-day period considered for the retention effect. During behavioral assessments, prefrontal cortical
activity will be measured to provide insights into the demand for increased executive control. The first aim of the
study will be to acquire preliminary effect size and response variance data to assess whether active adjuvant
tsDCS therapy combined with dynamic balance training enhances practice-related gains in balance and walking
performance and retention over time. The second aim of the study will be to establish evidence of increased
spinal excitability following tsDCS, positively correlating with gains in balance and walking functions. The
overarching hypotheses of the proposed study are that the positive effects of tsDCS on practice-related
enhancements and retention in balance and walking function will be related to increased spinal excitability. The
long term deliverable of this line of research will be a clinically feasible multi-modal intervention to assist in
preserving motor function and independence in older adults. The knowledge and experience gained from this
study will enable us to conduct larger studies to better understand the effects of aging on the spinal cord and to
test rehabilitation interventions to promote healthy aging among older adults.

Public health relevance
PROJECT NARRATIVE This study has the potential for significant public health impact due to the prevalence among older adults of balance and walking deficits, increased fatal and nonfatal falls, and impaired spinal cord neuronal structure and function that may affect spinal control of balance and walking. Transcutaneous spinal direct current stimulation (tsDCS) is one of the few available approaches for safe and feasible intervention of spinal circuitry that may improve spinal excitability and enhance practice-based rehabilitation of balance and walking. Successful completion of this study will provide an empirical basis for designing a novel tsDCS intervention in combination with balance exergaming, an approach that is feasible for translation into home- or community-based rehabilitation programs as a practical, cost-effective, and safe method for helping to preserve balance, walking, and independence among older adults.